Dendritic cell intrinsic UPR is critical for pathogen specific Th17 responses

Project Summary
Following ac+va+on, CD4 T cells diﬀeren+ate into one of three main eﬀector linages. The Th1, Th2 and Th17
lineage cells are generated in response to speciﬁc class of pathogens and are necessary to combat those
infec+ons. While we have comprehensive understanding of the speciﬁc cytokine cues as well as master
transcrip+on factors that are cri+cal for diﬀeren+a+on of each of these dis+nct T cell eﬀector lineages, the innate
sensing mechanisms that dictate speciﬁc diﬀeren+a+on of each of the T eﬀector lineages are not clear. The
pathogens that drive Th2 responses are fairly dis+nct but the Th1 and Th17 inducing pathogens share many
structural similari+es. Classical paFern recogni+on receptor ac+va+on by microbial ligands leads to genera+on
of inﬂammatory cytokine cues in the form of TNF, IL-6, IL-12, IL-1b, etc but we do not understand how CD4 T
cells integrate speciﬁc cues to generate a Th1 vs Th17 response. We posit here that host sensing mechanisms
that extend beyond the classical paFern recogni+on receptors might be involved in genera+ng unique cytokine
cues that speciﬁcally dictate genera+on of Th1 vs Th17 lineage cells. Our previous work has demonstrated that
following sensing of pathogens, conven+onal DCs can induce priming of naïve pathogen speciﬁc CD4 T cells in
vitro and the quality of the T cell response is dictated by the nature of the priming pathogen. Speciﬁcally,
s+mula+on of conven+onal DCs with the gut pathogen C. roden)um drives Th17 diﬀeren+a+on as opposed to L.
monocytogenes, sugges+ng a DC-dependent mechanism for Th17 diﬀeren+a+on. Transcrip+onal proﬁling of DCs
upon exposure to Th17 inducing (C. roden)um) versus non-inducing pathogens (L. monocytogenes and S. aureus)
and discovered that C. roden+um induced ac+va+on of the PERK pathway of unfolded protein response (DC-
UPR) that was integral to its ability to induce Th17 responses. C. roden+um’s ability to induce DC-UPR was shared
by its counterparts, the human enteric pathogens, EHEC and EPEC sugges+ng that this property was
evolu+onarily conserved in both the microbes and the hosts. More importantly, several autoimmune diseases
caused by Th17 cells are associated with the Unfolded protein response sugges+ng an integral link between ER
stress and outcome of T cell responses. In this applica+on we propose to inves+gate the importance of this UPR
induc+on from the perspec+ve of the microbe as well as the host and dissect the molecular mechanisms of
induc+on of the UPR and its impact on Th17 priming and diﬀeren+a+on. In aim 1, we will inves+gate the role of
DC-UPR in driving tailored immune responses against Th17 inducing pathogens. In aim, 2 we will iden+fy and
characterize the nature of the C. roden+um ligand that ac+vates the PERK pathway of UPR in DCs. In aim 3, we
will inves+gate the conserved nature of the UPR pathway in human enteric pathogens and human myeloid cells.
Successful comple+on of these aims will add to our fundamental understanding of genera+on of Th17 responses
and will provide us with tools to either increase or mi+gate development of Th17 response to enhance protec+on
against pathogens or protect against auto-immune inﬂamma+on.

Public health relevance
Project Narra+ve Following infec,on, the immune system generates pathogen speciﬁc T cells that are cri,cal for comba,ng the pathogen. We have discovered that genera,on of Th17 responses against a mucosal pathogen requires induc,on of an unfolded protein response in dendri,c cells. In this proposal we intend to study the molecular mechanisms by which the mucosal pathogens induce the unfolded protein response as well as the mechanisms by which this unfolded protein response speciﬁcally leads to genera,on of Th17 responses against mucosal pathogens.